Visual Function Core

During past year, NEI visual function core (VFC) continues to provide service and support to the NEI and NIH scientific community and to extramural researchers on non-invasive methods to evaluate visual function in various animal models. Based on community COVID-19 pandemic level, core adopted a hybrid of virtual and physical support to vision research environment. Variety virtual communication tools were used to maximize interactions with research scientists. VFC coordinated with researchers and animal facility to ensure safety for everyone and provided PPE and disinfection materials.

While electrophysiological recordings and eye imaging constituted most of the core service, behavior tests to determine opto-motor responses were also used by our researchers. NEI-VFC has helped users in design ERG recording and OCT imaging protocols specific for each research projects. Main accomplishments of the core for past year include:

1) Performed maintenance of all core equipment to ensure their optimal performance.

2) Added a new instrument (OptoDrum) to VFC service, provided training for using the instrument to measure rodent optomotor responses.

3) Acquired Photorefractor for measuring refractive power of rodent eye, and initiated testing refractive changes for mutant mouse.

4) Provided training and supervision to researchers on using core equipment, following safety and social distance rules to minimize person-to-person contact.

5) Provided training to scientific personnel on data analysis software, encouraging use of virtual communication when possible.

6) Providing consultations on using non-invasive methods to evaluate visual function to extramural research groups.

VFC provided training and help to users on analysis methods of electrophysiological, eye imaging, and behavior data, and on tools of generating final reports. Core also provided directions and instructions on installation of software needed for electrophysiological recording, behavior testing, and eye image data analysis.

In addition, core provided consultations and advises on various research projects. During the past year, core provided service and training to 39 scientists in 23 research groups (PIs), including 5 from other NIH institutes. NEI-VFC also provided consultations to several extramural research groups.